Growth Hormone Releasing Hormone Analog to Improve Nonalcoholic Fatty Liver Disease and Associated Cardiovascular Risk

7. Project Summary/Abstract
Nonalcoholic fatty liver disease (NALFD) is a growing threat to public health: 24% of all adults, and over half of
those with obesity or Type 2 diabetes (T2D), have NAFLD, which confers increased risk for liver failure, T2D,
and cardiovascular disease. NAFLD is predicted to be the leading indication for liver transplantation by 2020.
Although diet and exercise are proven to improve NAFLD, lifestyle changes are difficult to maintain for many
patients. Currently there are no highly effective pharmacologic treatments for NAFLD, and significant need
exists for therapeutic strategies to complement lifestyle changes. This proposal investigates a novel strategy to
reduce liver fat and inflammation using growth hormone releasing hormone (GHRH), which augments
endogenous GH secretion. On average, individuals with obesity have significant reductions in growth hormone
secretion, which we hypothesize to contribute to the pathophysiology of NAFLD by promoting a pro-
inflammatory milieu and altering hepatic lipid metabolism, increasing hepatic de novo lipogenesis. Our
preliminary data demonstrate that GHRH decreases liver fat in HIV-infected individuals and, in obese
individuals, reduces systemic inflammation and improves carotid intima-media thickness, a marker of
subclinical atherosclerosis. These data support the need to study the effects of GHRH on liver fat and histology
in obese individuals with NAFLD. The current research is proposed by collaborating Co-Principal Investigators,
Dr. Corey, a hepatologist with significant investigative and clinical research experience in NAFLD, and Dr.
Stanley, an endocrinologist with significant research experience in hormone dynamics, lipid metabolism, and
use of GHRH. The proposal will investigate the efficacy of GHRH in a 12-month randomized controlled trial in
76 obese adults who have established NAFLD on liver biopsy or ≥5% hepatic fat fraction on magnetic
resonance spectroscopy (MRS). A 6-month open-label phase will follow the randomized phase in order to
provide all participants with the opportunity to receive active treatment. The study hypotheses are as follows:
Aim 1: Compared to placebo, GHRH will significantly decrease hepatic fat as measured by MRS (primary
endpoint) and improve liver histology as assessed by reduction in NAFLD activity score and its individual
components. Aim 2: GHRH will alter hepatic lipid metabolism by decreasing hepatic de novo lipogenesis and
increasing expression of lipolytic genes, and will also reduce the hepatic expression of lipogenic, pro-
inflammatory and fibrogenic genes. Aim 3: Finally, given that cardiovascular disease is the leading cause of
death in NAFLD, and that preliminary data strongly suggest a benefit of GHRH to reduce subclinical
atherosclerosis, we hypothesize that GHRH will decrease coronary artery calcium scores and overall plaque
burden and will improve lipids and circulating markers of cardiovascular disease. If these hypotheses are
correct, the proposed studies will represent significant progress toward the development of therapies for
NAFLD in obesity.

Public health relevance
8. Project Narrative Non-alcoholic fatty liver disease (NAFLD) exists in 24% of US adults. It may lead to significant liver damage and is also associated with increased risk of diabetes and heart disease. Currently there are no highly effective pharmacological treatments for NAFLD. This proposal investigates whether growth hormone releasing hormone, a treatment that increases growth hormone secretion, will reduce liver fat, liver damage, and cardiovascular disease risk in patients with NAFLD.